Immunoengineering

Finalizing SARS-CoV-2 Research

We are finalizing the publication of our last works on COVID19 research which have all completed experimentation and are being submitted to scientific journals. Please refer to prior report regarding COVID19 research projects.

Biomaterials and Immunoengineering

The Section on Immunoengineering has continued their work on traumatic injury and inflammation associated with injury and medical device implantation during FY25. We have expanded our work on autoimmune conditions associated with chronic inflammation finding that microplastic presence within damaged tissue can cause formation of tertiary lymphoid clusters associated with B cell accumulation in muscle and autoantibody generation. We have also shown protective roles for killer-like regulatory cells in restraining these B cells through targeted killing of pathogenic helper T cells. We have also continued our work on predictive algorithms to identify markers of patient morbidity and mortality after traumatic injury and are beginning to launch a collaboration with the UMD Shock Trauma with goals of establishing an NIH/DOD collaborative network for human traumatic injury research. We have also successfully established a skeletal muscle on a chip model that we will be optimizing during FY26. This progress has been noted via the generation of publications, preprints, invitations for seminars, and awards to the principal investigator.